4D Nucleome Network Data Coordination and Integration Center

PROJECT SUMMARY
The goals of the 4D Nucleome (4DN) Data Coordination and Integration Center (DCIC) are to collect, store, curate,
display, and analyze data generated in the 4DN Network. We have assembled a team of investigators, staff
scientists, and developers with a strong track record in analysis of chromatin interaction data, image processing,
data visualization, integrative analysis of genomic and epigenomic data, data portal development, large-scale
computing, and development of secure and ﬂexible cloud technologies. In the ﬁrst phase of the 4DN Project,
we have developed the 4DN Data Portal as a central resource with tools for data submission, curation, analysis
and quality control, visualization, exploration, and download. The portal provides an easy-to-navigate interface
for accessing raw and intermediate data ﬁles, allows for programmatic access via APIs, and incorporates novel
analysis and visualization tools developed by DCIC as well as other Network members. In the second phase of the
4DN Project, we will continue to support the research activities by the 4DN Network, and to lead the creation of a
well curated 4DN data resource for the scientiﬁc community. At the same time, we propose to enhance the utility
of the 4DN Scientiﬁc Data and the Data Portal in multiple ways: i. We will create a platform to integrate imaging
and sequencing data and support the creating of reference nuclear maps in a common coordinate system; ii. We
will provide support for 4DN Projects on Human Health and Disease with customized ontology applications and
protected data management; iii. We will develop new cloud platform capabilities to bring user analyses to the
4DN Data Portal, and apply cost-efﬁciency improvements to support increasing data volumes; iv. We will perform
regular outreach activities to raise awareness about the data and tools generated by the Network and DCIC.
Overall, we will ensure that the data generated in 4DN will have maximal impact for the scientiﬁc community.

Public health relevance
PROJECT NARRATIVE Characterization of chromatin interactions and higher-order nuclear organization will be important for a better understanding of gene regulation in disease processes. We will develop a platform for data collection, curation, visualization, and analysis. This will enable data sharing and integrative analysis of the massive amounts of data that will be generated in the 4D Nucleome Network.